Evaluating cerebrovascular reactivity in autistic and non-autistic children using resting-state functional MRI

Project Summary/Abstract
Many studies utilize resting-state functional magnetic resonance imaging (rsfMRI) metrics, such as
functional connectivity (FC), to study the neural underpinnings of autism and identify functional brain networks
related to autistic behaviors. However, these findings remain inconsistent, with reports of underconnectivity and
overconnectivity in multiple resting-state networks. FC measures the temporal correlation between the blood
oxygen level dependent (BOLD) signal of distinct brain regions. In fMRI, the BOLD signal indirectly measures
neuronal activity by detecting changes in oxygenated blood flow, which occurs through local blood vessel
dilation. In addition to neuronal activity, changes in brain vascular function can affect local oxygenated blood
flow, and thus the BOLD signal within a region and FC between regions. Characterizing these cerebrovascular
effects on FC is critical to understanding neuronal and vascular sources of connectivity in populations with
potential cerebrovascular heterogeneity, such autism or early development. In this study, we utilize a novel, non-
invasive method to characterize cerebrovascular reactivity (CVR), the vasodilatory capacity of cerebral blood
vessels, in autistic and non-autistic children, based solely on rsfMRI BOLD signals (Aim 1). We then use this
novel information to investigate the mechanism linking vascular function to FC, using the amplitude of low
frequency fluctuations (ALFF), a resting-state measure of local BOLD amplitude that has been associated with
both neuronal and vascular physiology (Aim 2). Using data from the Autism Phenome Project (APP), a
longitudinal neuroimaging program that specializes in early age scanning (2-12 years old) in autistic and non-
autistic children, we will compare age-trajectories of CVR and its effect on FC in autistic and non-autistic children
starting from 2 years old. In acquiring and analyzing data from young autistic and non-autistic participants, I will
receive unique clinical and neuroimaging training, specifically in autism, to support my career as an independent
investigator, developing novel neuroimaging biomarkers to characterize cerebral physiology in autism.
Ultimately, providing insight into cerebrovascular differences and enhancing FC interpretations in autism, starting
from early age, will help disentangle its heterogeneity to inform meaningful, early interventions.

Public health relevance
Project Narrative Many studies utilize resting-state functional magnetic resonance imaging (rsfMRI) metrics, such as functional connectivity (FC), to study the neural underpinnings of autism; however, these findings remain inconsistent, potentially due to heterogeneity in cerebrovascular function, which modulates the blood oxygen level dependent (BOLD) signal of rsfMRI, in addition to neuronal activity. In this study, we utilize a novel, non-invasive method, based solely on rsfMRI BOLD signals, to longitudinally compare cerebrovascular reactivity (CVR), or the vasodilatory capacity of cerebral blood vessels, in autistic and non-autistic children across development (2-12 years old); and potentially identify a subgroup of autism with cerebrovascular differences. We then apply to this novel information to investigate the mechanism linking vascular function to FC and ultimately improve neuronal and vascular interpretations of functional connectivity in autism, during a period of rapid cerebrovascular growth.